Pediatric Hospital Epidemiology and Outcomes Research Training Program

PROJECT SUMMARY/ABSTRACT
The Pediatric Hospital Epidemiology and Outcomes research Training (PHEOT) Program at Children’s
Hospital of Philadelphia (CHOP) is a 2-year postdoctoral research fellowship designed to provide physicians
with training in hospital epidemiology and outcomes research. The PHEOT program trains the next generation
of physician scientists to best measure, investigate, and improve outcomes and patient safety for hospitalized
children. Through a combination of formal coursework and mentored research projects, physician trainees
develop expertise in comparative effectiveness research, exposure and outcomes measurement, severity
adjustment, and decision analysis as they relate to pediatric hospital care. Five post-doctoral trainees
simultaneously participate in the PHEOT program across the 2 years of training. Trainees benefit from the
combined resources of two Centers at the CHOP Research Institute: The Center for Outcomes Research and
the Center for Pediatric Clinical Effectiveness, as well as a rich array of “natural laboratories” for evaluating and
improving health care processes and outcomes, including the Pediatric Advanced Care Service, the General
Pediatrics Inpatient Service, the Center for Simulation, Advanced Education and Innovation, and the Center for
Quality, Safety, and Analytics. All fellows complete Masters-level coursework in study design and biostatistics
culminating in either the Master of Science in Clinical Epidemiology (MSCE) or the Master of Science in Health
Policy Research (MSHP) degree at the University of Pennsylvania. Each fellow is assigned a mentorship team
consisting of seasoned methodology, content, and biostatistics mentors who supervise the trainee in the
successful completion and publication of at least one research project. PHEOT fellows also benefit from a host
of professional development activities, including works-in-progress sessions, a weekly seminar series to teach
academic medicine skills, and opportunities to present research at national meetings.

Public health relevance
PROJECT NARRATIVE The rapid pace of pediatric medical and surgical innovation combined with an increasing prevalence of infants, children, and adolescents with medical complexity has resulted in emerging clinical, operational, and ethical challenges to hospital-based pediatric care. Training of healthcare professionals in hospital-based epidemiology and outcomes research is critical to the continued excellence of pediatric inpatient care in the United States. The PHEOT program trains the next generation of physician scientists to best measure, investigate, and improve outcomes and patient safety for hospitalized children.